Expansion of Tumoroid Models for Precise Treatment of the Rectal Cancer Patient

PROJECT SUMMARY/ABSTRACT: We propose to develop rectal cancer organoids (tumoroids) as
individualized models and to build a large rectal cancer tumoroid repository. Research on rectal cancers is
hampered by the paucity of models. Of the few existing in vivo models of rectal cancer, none place the tumors
in the rectal lumen, so the models fail to mimic the correct anatomic environment and local invasion. The
existing models also have not been observed to metastasize. Another problem is that we lack accurate means
to predict whether individual rectal cancer patients will respond to chemotherapy or radiation, both of which are
part of the current standard of care. These challenges can be addressed by patient-derived tumoroids, which
can be grown in 3-dimensional culture ex vivo or implanted into mice, offering a flexible research platform. In
preliminary results, we have derived tumoroid lines from multiple patients' rectal cancers and found them to
resemble the corresponding patient tumors. The tumoroids, when implanted in mice endoluminally (i.e. in the
rectum), formed locally invasive tumors capable of metastasis. Moreover, we found tumoroids to have clinically
relevant responses to chemotherapy and radiation. Thus, drawing from these preliminary data, we
hypothesize that rectal cancer tumoroids mirror the traits of their original tumors, can be used to predict
patients' response to therapy, and, when implanted endoluminally into mice, can serve as an optimal model of
rectal cancer.
We plan to develop 100 new tumoroids, which we expect to encompass much of the diversity of human rectal
adenocarcinoma. Tumoroids will be analyzed in ex vivo culture and in the endoluminal implantation and
conventional flank injection models. In these settings, we will test whether the tumoroid accurately reflects its
tumor of origin in terms of mutations, histology, and gene expression. We will determine whether response of
the tumoroids to patient-specific chemotherapy and radiation can predict the corresponding patient's response,
and whether individual human rectal cancers are more accurately modeled by endoluminal implantation than
by flank injection. Leveraging our tumoroid biorepository, we will also identify molecular drivers of
chemotherapy response by comparing tumoroids derived from patients with complete response to those with
incomplete response and determine the mechanism of chemoresistance in SMAD4-deficient tumoroids.
Finally, to integrate our findings into a comprehensive platform for broad use, we will develop a rectal cancer
tumoroid biorepository seamlessly integrated with online pathologic, genomic, and model-specific information.
We anticipate that the proposed research will credential tumoroids as accurate models for rectal cancer
research and for predicting patient responses to therapy. The large tumoroid biorepository is likely to stimulate
research on new treatments for rectal cancer. The ultimate result will be new treatment options and better
treatment selection for patients affected by this deadly disease.

Public health relevance
PROJECT NARRATIVE Rectal cancer represents a growing problem, because it is increasingly diagnosed in people in the prime of life; however, research into new treatments has been hampered because current models of rectal cancer poorly represent patient tumors. Our goal is to develop rectal cancer organoids (tumoroids) as models for rectal cancer research, to establish whether they allow for prediction of individual patients' responses to chemotherapy or radiotherapy, and to use them to understand the molecular basis of treatment response and resistance. The ultimate result will be expansion of patient-specific research tools, accelerated discovery of new treatment options for rectal cancer patients, and eventually better treatment decisions for individual patients.